In vivo ACL mechanics and risk factors for injury

Abstract
An estimated 400,000 anterior cruciate ligament (ACL) injuries occur yearly in the United States. Most ACL
injuries are non-contact, occurring during rapid deceleration movements such as jumping and cutting.
Importantly, the risk of early-onset osteoarthritis (OA) persists regardless of whether ACL reconstruction is
performed. Therefore, identifying risk factors for non-contact ACL injury is of great clinical importance.
The function of the ACL is to resist tibiofemoral motion during the intense forces associated with dynamic
activity. Therefore, measuring the dynamic elongation patterns of the ACL functional bundles will provide imaging
biomarkers of elevated tension within the ACL. As the ACL fails under tension, factors associated with elevated
ACL bundle elongations reflect increased vulnerability to injury.
Non-contact ACL injuries are 2-6x more likely in females as compared to males. Patients with prior ACL
injury are up to 15x more likely to sustain injury to their uninjured contralateral knee than uninjured controls.
Finally, while controversial, some studies indicate that fatigue increases injury risk. However, there remains
limited in vivo data to describe ACL bundle elongations during relevant dynamic activities (such as jumping and
cutting) in these groups. Because different studies suggest that different motion patterns are associated with
non-contact ACL injury, the kinematic risk factors for this injury remain unclear. Additionally, studies suggest that
a number of characteristics of femoral, tibial, and ACL morphology are related to injury risk. However, it remains
unclear how these kinematic and morphologic factors interact to influence ACL tension during relevant dynamic
activities. Thus, quantifying the influence of these factors on in vivo ACL bundle elongations in these high risk
groups addresses a critical barrier to our understanding of what elevates ACL injury risk.
Thus, we propose to utilize a novel in vivo multimodal imaging methodology developed by our lab to assess
the impact of 6DoF kinematics and characteristics of knee morphology on in vivo ACL bundle elongations
(defined as change in length normalized to an unloaded reference length). These relationships will be assessed
during jumping and cutting activities in three potentially high risk populations. Specifically, we will investigate
these relationships Aim 1.) in both sexes, Aim 2.) in the uninjured knees of patients with prior ACL injury and
control knees, and Aim 3.) pre- and post-fatigue. Relevant biological variables including sex, age, BMI, race,
isokinetic muscle strength, sport participation, and activity level, will also be considered as covariates that may
impact ACL bundle elongations. Furthermore, interactions between covariates will be explored to assess
differential effects of one covariate across levels of another. Thus, the proposed studies will have high impact
because they will 1.) address a fundamental gap in knowledge regarding the causes of ACL injury 2.) identify
those who are at high risk for injury and 3.) identify those who are best targeted for intervention strategies.

Public health relevance
Project Narrative Non-contact anterior cruciate ligament (ACL) injuries are accompanied by severe short- and long-term consequences, including early-onset osteoarthritis. The proposed research will identify kinematic and morphologic factors that are associated with elevated tension within the ACL functional bundles. Since elevated ACL tension reflects increased vulnerability to ligament failure, the proposed studies will provide crucial criteria that will identify those who are at high risk for injury and also enable targeted intervention strategies to those who are likely to benefit from injury prevention training.